Clinical Sample Database and Proteomics

PROJECT SUMIVIARY (See instructions): Core C will provide support for research sample collection for BMT patients and ensure proper and consistent quality control regarding the collection, processing, archiving and distribution of samples. Core C will also ensure quality control of the clinical status and endpoints of individuals whose samples are collected and analyzed. In addition, Core C will continue to support exploratory proteomic profiling of clinical research samples from allogeneic BMT patients. During this last cycle. Core C has been instrumental in the development and validation of a four biomarker panel of GVHD. The services provided by Core C will include the following: 1. To collect, process, store, and distribute patient derived research samples 2. To collect data for, quality control, and maintain the integrated comprehensive patient database 3. To provide cutting edge proteomic analysis technology

Public health relevance
Allogeneic hematopoietic stem cell transplantation is a potentially curative therapy for many malignant diseases whose applicability has been impeded by the development of its most serious complication, GVHD. Strategies that mitigate GVHD will allow for better harnessing of this effective therapeutic modality to treat many patients with hematological cancers.